Mechanisms regulating vimentin-dependent invasion of the brain by Listeria monocytogenes

Project Summary
Listeria monocytogenes (Lm) is an intracellular bacterial pathogen capable of invading numerous host
cell types. Lm infections can lead to severe disease in humans and most often affects immunocompromised
individuals, pregnant women, and the elderly. Of particular concern is the ability of Lm to invade the central
nervous system (CNS), leading to life-threatening meningitis and encephalitis. The identity of factors necessary
to facilitate Lm brain infection has remained unclear. We have recently shown that a Lm surface protein, InlF,
is required for successful colonization of the brain in mice. Moreover, we have determined that InlF binds
vimentin, a cytosolic intermediate filament protein also present on the surface of brain endothelial cells. We
hypothesize that InlF-vimentin interaction is required for Lm passage across the blood-brain barrier (BBB) to
establish an infection in the brain. The focus of this proposal is to elucidate how the InlF-vimentin interaction
mediates invasion of host cells in vitro and Lm infection of the brain in vivo. In Aim I, in vitro infection assays
will be used to determine how InlF interacts with vimentin to mediate invasion of host cells. Confocal
fluorescence microscopy and gentamicin protection assays will be used to directly examine the ability of InlF-
expressing Lm to interact with brain microvascular endothelial cells. Biochemical approaches will be used to
further characterize InlF-vimentin protein binding and identify the regions of vimentin involved in the InlF-
vimentin protein-protein interaction. The mechanisms that regulate cell surface exposure of vimentin are
unknown. We hypothesize that cellular membrane repair pathways facilitate redistribution of cytosolic vimentin
to the surface of host cells. Cell biological studies will be performed to determine the role of membrane repair
pathways for the localization of vimentin to the host cell surface. Additionally, potential vimentin co-receptor
candidates previously identified by mass spectrometry will be examined to determine their role in InlF-mediated
invasion of brain endothelial cells. In Aim II, the contribution of the InlF-vimentin interaction to Lm infection in
vivo will be determined by infection studies in normal and vimentin knockout mice. In vitro infection assays and
fluorescence microscopy will be performed with primary brain cells cultured from normal and knockout mice to
determine if InlF mediates invasion of distinct primary brain cell types (astrocytes and neurons) and determine
the importance of vimentin and potential co-receptors for infection. Gentamicin protection assays with primary
mouse endothelial cells will also be performed to determine if InlF is required for invasion of primary cells that
constitute the BBB. Finally, infection of mice with cell-to-cell spread-defective ΔactA or ΔactA/ΔinlF-derived Lm
strains will determine the in vivo contribution of InlF for colonization of the brain by direct invasion vs. cell-to-
cell spread. The proposed studies will provide insights into the protein-protein interactions and cellular
mechanisms facilitating Lm invasion of the brain and may identify novel targets for preventing infections of the
brain by Lm and other microbial pathogens.

Public health relevance
Project Narrative Listeria monocytogenes is an intracellular bacterial pathogen capable of causing severe infections in humans, including meningitis and encephalitis. The focus of this proposal is to determine how a L. monocytogenes surface protein, InlF, interacts with host cell surface vimentin to mediate bacterial invasion and colonization of the brain. The long-term goal is to provide further insights into how intracellular pathogens invade the brain and to identify novel approaches to prevent bacterial infections of the brain.